Exploiting a high-precision phenotypic map to illuminate environmental sensing by a fungal meningitis pathogen

ABSTRACT
Determining the molecular function of myriad unannotated pathogen genes remains extremely challenging, yet
such knowledge is critical for understanding pathogen biology and developing new drugs. Genome-wide profiling
in model yeasts has shown that genes that function in the same pathway show correlated patterns of genetic
interactions (double mutant phenotypes) or phenotypes in response to small molecule challenges (chemical-
genetic phenotypes). Such studies of gene-gene co-fitness have produced numerous important functional
insights by identifying new components of pathways or connecting pathways. However, its application to fungal
pathogens at a genomic scale has yet to be achieved. Cryptococcus neoformans, the focus of our work, is the
most common cause of fungal meningitis, causing >100,000 fatalities annually. We constructed a gene deletion
collection for C. neoformans corresponding to ~4400 knockout strains. To understand gene function, we
developed a very high-precision method (replicate r2 ~ 0.98) for quantifying the abundance of gene deletions in
pools (KO-seq). We profiled the entire knockout collection under >130 diverse in vitro challenges, including small
molecule/drug treatments. We also quantified the fitness of the knockout collection in pools in mice. The high
precision of the in vitro measurements enabled the clustering of gene deletion strains based on their phenotypic
signatures, revealing numerous high-confidence clusters, most of which correspond to conserved
pathways/complexes, supporting the exquisite quality of the data. Importantly, we also discovered many new
clusters containing unstudied genes. Below, we focus on three clusters related to fungal sensing of the
environment, which is critical for pathogenesis and offers targets for antifungal drug development. Focusing on
this theme, we hypothesize that the phenotypic map of C. neoformans will enable the identification and study of
new components of key pathways relevant to pathogenesis and drug development. To accomplish this goal we
will 1) Dissect function of a new component of a conserved pH sensing pathway, 2) Dissect function of new
components of the calcineurin pathway, and 3) Test the model that negative regulation of a putative cell wall
amylase is essential for survival under host-like conditions: Successful accomplishment of these aims will
illuminate important new aspects of C. neoformans environmental sensing mechanisms highly relevant to drug
development and pathogenesis while demonstrating the utility of high-precision phenotypic measurements under
diverse environmental conditions to decipher a deadly human fungal pathogen.

Public health relevance
PROJECT NARRATIVE We have developed the first genome-scale, high-precision phenotypic map for the human meningitis pathogen Cryptococcus neoformans, a yeast responsible for ~20% of HIV/AIDS deaths. In this project, we will investigate previously unstudied proteins predicted by our map to be required for sensing and surviving key environmental cues, including pH, membrane stress, and host-like stresses. Successful accomplishment of this work will illuminate important new aspects of pathogen environmental sensing mechanisms highly relevant to drug development and pathogenesis while demonstrating the utility of high-precision phenotypic measurements under diverse environmental conditions to decipher a deadly human fungal pathogen.